DMPK CONSULTING SUPPORT SERVICES

Drug Metabolism and Pharmacokinetics (DMPK) consultants may be required to
evaluate PK study protocols and data, assist with study design, and advise NIH staff on
the establishment of milestones related to DMPK. Specific consulting responsibilities
will depend on the expertise of the individual consultant and the needs of individual
projects. DMPK-related consultation services may be required on an ad hoc basis or on
LDTs.
The role of the Drug Metabolism and Pharmacokinetics consultant may include but is not
limited to the following responsibilities and tasks:
• In partnership with other consultants, contractors, and the NIH staff, advise,
strategically plan, and manage pharmacokinetic (PK) programs to facilitate assay
development, exploratory chemistry, lead optimization, formulation activities,
IND enabling, and clinical studies.
• Serve as the PK expert in order to identify potential drug discovery and
development challenges such as lead identification and lead development and
suggest strategies to address these challenges.
• Collaborate on design of investigative PK studies, PK/PD strategy, experimental
design, data analysis and interpretation for discovery and translational projects in
support of NIH drug discovery and development projects.